Examining Early Intervention Obstructive Sleep Apnea Treatment on Long-Term Outcomes in Veterans with SUD/PTSD in a Residential Treatment Program

Objectives. Substance use disorder (SUD) and posttraumatic stress disorder (PTSD) frequently co-occur
and having one condition worsens the course of the other. Individuals with both disorders exhibit worse
functioning across a number of domains than individuals with either disorder alone. This is especially true in
residential settings where both disorders are more severe than outpatient settings. Compared to Veterans with
a single disorder, Veterans with SUD/PTSD also are more likely to have suicidal ideation and to have
attempted suicide. Examining treatable conditions that are associated with improved SUD and PTSD
outcomes, such as obstructive sleep apnea (OSA), can maximize treatment efficacy for Veterans at a critical
time in recovery.
OSA is highly comorbid with both PTSD and SUD with upwards of 67 to 83% of Veterans with SUD or
PTSD also having OSA. Further, untreated OSA is associated with worse functional impairment across
multiple domains, worse quality of life, worse PTSD, and higher substance use and relapse rates. Importantly,
untreated OSA also contributes to higher suicide attempts and completion. Positive airway pressure (PAP) is
the gold standard treatment for OSA with large effects on multiple domains of functioning, quality of life, PTSD
symptoms, physical functioning, lower depression, and better emotional coping. Unfortunately, screening and
treating Veterans for OSA is not a part of clinical practice for SUD or PTSD treatment; as such the average
wait time for individuals to get PAP therapy is upward of two years. Despite the widespread dissemination of
knowledge regarding the detrimental effects of untreated OSA and the incredible effectiveness of PAP
treatment, OSA is rarely screened for or treated in patients with SUD or PTSD, with approximately 80% to 90%
of Veterans with OSA remaining undiagnosed and untreated.
Methodology. We aim to examine the effects of PAP treatment on Veterans with PTSD and SUD on a 28-
day residential unit. We are proposing a randomized controlled study comparing two groups: an early
intervention PAP treatment group receiving PAP treatment while on the residential unit, compared to a waitlist
control group who will receive PAP treatment at 3-months post-discharge follow-up. Participants will be 194
male and female Veterans on the residential SUD and PTSD unit with SUD, PTSD, and OSA. Our primary aim
is to determine the relative efficacy of PAP treatment on the SUD/PTSD unit, as compared to waitlist control, in
reducing problematic substance use, PTSD symptoms, and suicidal ideation, while improving functioning
among Veterans with comorbid SUD/PTSD at 3-months post-treatment follow-up. We will also compare PAP
adherence rates on PTSD/SUD/functioning outcomes within the PAP treatment group (3-months). Finally, we
plan on comparing adherence rates between the two treatment groups at the 6-months post-treatment follow-
up assessment.
Examining OSA treatment for SUD and PTSD is highly relevant to the goals of RR&D and the VA to
maximize treatment efficacy for Veterans and has the potential to improve functional and psychological
recovery for a highly prevalent and highly impaired population of Veterans. This research will directly impact
functional outcomes, SUD recovery, and PTSD symptoms in already vulnerable Veterans struggling with SUD
and PTSD. The successful completion of this project will help improve the practices that drive treatment for
Veterans who have both SUD and PTSD. The fundamental rationale for this study is to improve the evidence
base that informs how patients with SUD and PTSD can attain sustained recovery from both of these
disorders.
Colvonen - 1

Public health relevance
Substance use disorder (SUD) and posttraumatic stress disorder (PTSD) frequently co-occur and having both disorders is associated with greater psychological and functional impairment than having either disorder alone. This is especially true in residential settings where both disorders are more severe than outpatient settings. Obstructive sleep apnea (OSA) is highly comorbid with both disorders and untreated OSA is associated with worse functional impairment across multiple domains, worse quality of life, worse PTSD, higher suicidal ideation, and higher substance use and relapse rates. Treating OSA with evidence-based positive airway pressure (PAP) in Veterans with SUD/PTSD on a residential unit is a logical way to maximize treatment adherence and treatment outcomes. This study compares OSA treatment while on a SUD/PTSD residential unit to a waitlist control group. We hypothesize that treating OSA on the residential unit, compared to the waitlist control, will have better functional, SUD, and PTSD outcomes.